Building a multi-factor etiological model of the emergence of general psychopathology (the "P factor") in adolescence with multi-modal neuroimaging in ABCD

Abstract
There is substantial evidence that psychopathology is structured hierarchically. In addition to two major specific
factors, internalizing and externalizing, there is a single overarching general factor, the “P factor”, that explains
a sizable share of variance in psychiatric symptoms. The P factor model represents a major recent advance in
our understanding of the architecture of psychopathology. However, there is a critical gap in our current
knowledge: We have little understanding of the neurodevelopmental etiological factors that produce the P
factor during youth.
We have an ideal opportunity to address this gap with the Adolescent Brain Cognitive Development (ABCD)
longitudinal study (n=11,875; 4 biennial waves of data over the course of this five-year grant). We have
formulated a Dual Dysmaturation Model in which the P factor arises from altered maturation during
adolescence in two systems: executive control systems (leading to globally reduced higher-order cognition and
inhibitory control) and impulse generation systems (leading to globally elevated impulse generation). We have
also undertaken a comprehensive analysis of psychopathology data in ABCD to derive and validate a
superordinate general psychopathology factor (“P factor”). Our overarching aim in this project is to build on
these results and delineate the multi-factor etiology of the P factor in youth in ABCD, integrating knowledge
across socio-environmental, psychological, neural, and genetic levels of analysis.
More specifically we seek to achieve four aims. Aim 1 uses a latent growth modeling approach to quantify co-
development of psychological variables (including executive functions, negative emotions, and aggressive
impulses) with the emergence of the P factor over adolescence. In Aim 2, we use advanced methods to
fractionate brain imaging maps into a small number of cohesive components. We then use latent growth
modeling to identify brain components that co-develop with the P factor. For Aim 3, we delineate genetic
factors that contribute to the P factor. For this aim, we identify brain components that mediate the relationship
between polygenic risk for the P factor and the emergence of the P factor in late adolescence. For the Aim 4,
we integrate the preceding factors (psychological, neural, and genetic) with additional socio-environmental
variables to build an overall nomological network for the emergence of the P factor, and we distinguish this
network from analogous networks for the emergence of internalizing and externalizing specific factors.
By bringing together the seminal ABCD dataset and advanced multivariate multi-modal neuroimaging methods,
this project will give us important new mechanistic insights into the multi-factor neurodevelopmental etiology of
the P factor. This knowledge is a key input to downstream research programs, such as programs that seek to
identify high-risk youth or to develop interventions that mitigate or block the emergence of psychopathology.

Public health relevance
Project Narrative Convergent research finds a single overarching general factor, the “P factor”, contributes to a broad array of psychiatric symptoms, but we know very little about what factors influence the neurodevelopment of the P factor during youth. This project addresses this gap in knowledge by leveraging data from the seminal Adolescent Brain Cognitive Development (ABCD) study. Using advanced multivariate neuroimaging methods, we systematically map how social/environmental, psychological, and genetic factors shape brain structure and function during adolescence which in turn leads to the emergence of the P factor.